Mapping and prediction of quantitative transcription factor dosage effects to understand variation in craniofacial morphology and disease

PROJECT SUMMARY
Accumulating evidence suggests robustness of transcriptional regulation, yet human genetic studies indicate
phenotypic sensitivity to transcription factor (TF) dosage in both complex traits and rare disorders, motivating
quantitative studies of TF dosage effects. These features are exemplified by the development of the human
face, which is frequently disrupted in a range of syndromes with typical features. The aim of this proposal is
to develop and apply tools to precisely modulate dosage of craniofacial TFs in cranial neural crest cells, the
progenitors of the face, and assess effects across multiple biological levels – molecular, cellular, and
morphological. The proposal initially focuses on SOX9, using diverse approaches to understand the rules
that determine which regulatory elements and genes are sensitive to SOX9 dosage (Aim 1), as well as their
phenotypic consequences (Aim 2). Then, such rules will be generalized to five additional craniofacial TFs
(Aim 3) and used to dissect mechanisms underlying genetic variants associated with craniofacial
morphology or disease (Aim 4). These studies will reveal drivers of craniofacial morphological and disease
variation, provide general insights into transcriptional regulation, and help transform our approach to
studying TF function, from binary to quantitative in nature.
The proposed research, along with a comprehensive plan for my career development, combines my scientific
background and postdoctoral training in functional genomics, gene regulation, and human genetics with
opportunities for additional training in machine learning, mouse genetics, and morphological analysis. I will
be mentored by Drs. Joanna Wysocka and Jonathan Pritchard in a vibrant scientific environment (Stanford
Chemical and Systems Biology) and receive additional training from my advisory committee of Drs. James
Ferrell, Anshul Kundaje, and Benedikt Hallgrimsson.
My transition to independence will be facilitated by participation in both scientific and non-scientific trainings
and workshops, as well as experience in presenting my work at scientific conferences. I will also gain
experience mentoring students and technicians, and will hone my grant management and writing skills.
Collectively, my mentors have guided over 25 of their former postdocs to independent academic research
positions, and they will provide practical advice and feedback during my faculty job search.
My long-term career goal is to direct an independent research program aimed at understanding the
molecular underpinnings of quantitative variation in craniofacial morphology and disease risk. So far I have
achieved significant progress towards this goal through my research experience, publications, and
engagement with the broader scientific community. I firmly believe, however, that a K99 mentored phase
will maximize my chances for success by providing access to key resources and training that would be
otherwise lacking from my postdoctoral experience.

Public health relevance
PROJECT NARRATIVE The research proposed here will systematically quantify the effects of craniofacial transcription factor dosage changes on molecular, cellular, and morphological phenotypes. This work will provide: (1) mechanisms underlying sensitivity to transcription factor dosage in normal-range and disease-associated variation, (2) insights into the specific facial phenotypes observed in a range of craniofacial syndromes, and (3) basic insights into the mechanisms of transcription-factor mediated regulation. Finally, by driving forward our understanding of craniofacial variation and disease, the proposed research will nominate key genes and pathways that one day could inform disease prediction and/or therapeutic development.